Delineating developmental programs driving tumorigenesis in triple-negative breast cancer

PROJECT SUMMARY
Triple-negative breast cancer (TNBC) is the deadliest and 2nd most common subtype of breast cancer in the
United States. Although promising new drugs based on PARP inhibition and immunotherapy can extend survival
in selected patients, 1 in 3 patients die from TNBC. Increasing evidence suggests that human breast tumors
harbor immature cancer cells which are a distinct subset of tumorigenic cancer cells, are less-differentiated,
capable of replenishing cancer cell populations indefinitely, and strongly implicated in drug resistance.
Unfortunately, existing marker genes for studying these cells are not specific, precluding rational drug
development. We hypothesize that precise identification of immature cancer cells could present new
therapeutic opportunities to revolutionize TNBC treatment. We recently showed that the number of
expressed genes per cell is a powerful surrogate of cellular differentiation status independently of known
marker genes. We leveraged this finding to develop CytoTRACE, a new framework for predicting cellular
differentiation status from single-cell RNA sequencing (scRNA-seq) data. Our published data show that immature
cancer cells predicted by CytoTRACE preferentially express genes essential for tumorigenicity in TNBC. In pilot
data, we identified 10 putative cancer cell populations, including at least 3 immature ones, from scRNA-seq data
of 19 primary breast tumors. Here, we propose to study over 800 TNBC patients to determine whether immature
cancer cells represent at least 3 distinct populations (Aim 1); differ by key clinical covariates (Aim 2); and are
clonogenic and produce specific progeny populations predicted in silico (Aim 3). To accomplish these aims, we
will leverage new analytical methods, including a deconvolution approach for integrating scRNA-seq with bulk
tumor transcriptomic data in order to characterize cellular heterogeneity at scale. Successful completion of the
proposed project will validate and refine our pilot data toward advancing our understanding of cancer cell
populations, especially immature cells, in TNBC. As such, we expect this study to facilitate new opportunities for
the development of targeted drugs to improve TNBC outcomes.

Public health relevance
PROJECT NARRATIVE Triple-negative breast cancer (TNBC) is a common, high-mortality disease, with no generally effective therapies. Immature cancer cells are strongly implicated in therapy failure but are challenging to identify. New analytical tools will allow us to determine the molecular diversity and tumorigenic potential of immature cancer cells in TNBC, thereby laying a foundation for the development of new therapies to improve TNBC outcomes.